Integrin regulation of insulin sensitivity

SUMMARY
Insulin resistance is a major risk factor for cardiovascular disease which in turn is the major cause of morbidity
and mortality in diabetes. The prevalence of insulin resistance is increasing in the setting of a global obesity
epidemic. The long-term goal is to understand the role of the integrin family of cell surface matrix receptors in
regulating obesity and insulin resistance. The overall objective of this application is to elucidate the role of the
αvβ5 integrin and its ligand, Milk Fat Globule Epidermal Growth Factor like 8 (Mfge8), in regulating skeletal
muscle insulin resistance. The central hypothesis is that insulin accelerates movement of MFGE8 through the
endoplasmic reticulum/Golgi network and subsequently to the outer plasma membrane where it binds αvβ5;
αvβ5 subsequently interacts with a complex containing the insulin receptor leading to dampening of insulin
receptor signaling and that disruption of the MFGE8-integrin pathway will ameliorate insulin resistance. These
hypotheses are based on data showing that acute disruption of the MFGE8/αvβ5 pathway modulates skeletal
muscle insulin-mediated glucose uptake and tyrosine phosphorylation/activation of the Insulin Receptor β
subunit (IRβ) and the Insulin Receptor Substrate-1 (IRS1) coupled with evidence that the insulin receptor
interacts directly with the αvβ5 integrin and that this interaction is strengthened by insulin as well as by MFGE8
(1). These hypotheses will be tested through 3 specific aims: 1) determining the cellular mechanism by which
insulin induces cell surface enrichment of MFGE8; 2) investigating whether the MFGE8-αvβ5 pathway induces
insulin resistance by regulating dephosphorylation of IRβ and IRS1; 3) investigating the contribution of skeletal
muscle MFGE8/β5 signaling in regulating basal and obesity-induced insulin resistance. Aim 1 will determine
how insulin promotes skeletal muscle plasma membrane Mfge8 localization and binding to αvβ5 which then
activates downstream signaling leading to reduced insulin sensitivity. Aim 2 will examine how activation of the
Mfge8-integrin axis leads to increase activity of the phosphatase PTP1β which subsequently dephosphorylates
and inactivates the insulin receptor in skeletal muscle leading to reduced plasma membrane translocation of
Glucose Transporter 4 and reduced glucose uptake. Aim 3 will examine the therapeutic potential of systemic
blockade of the β5 integrin or MFGE8 in ameliorating insulin resistance in a mouse model of diet-induced
obesity and insulin resistance and the relative contribution of skeletal muscle to this process. The proposed
research is innovative, because it identifies a mechanism by which insulin activates an integrin pathway that
subsequently feeds back to terminate insulin signaling. The proposed research is significant because it has the
potential to inform the development of novel therapeutics that treat insulin resistance.

Public health relevance
Project Narrative The proposed research is relevant to public health because a detailed understanding of the mechanisms regulating insulin receptor signaling and insulin sensitivity can identify new therapeutic targets that can be manipulated for the treatment of diabetes. Therefore, the proposed studies are relevant to the NIH mission to seek fundamental knowledge about the nature and behavior of living systems with the goal of using that knowledge to enhance health, lengthen life, and reduce illness and disability.